Genetic variants that affect the airway epithelium to drive obstructive lung disease

Project Summary
Effective treatments for COPD are disappointingly limited because the subtypes of this complex disease are not
well defined. COPD may be initiated by susceptibility of different cell types to pollutants, including epithelial cells,
endothelial cells, fibroblasts, dendritic cells, T cells, or any other cell type. We have shown that primary human
airway epithelial cells (HAECs) with an arginine (HAECArg ) compared with a proline ( HAECPro) at locus 72 of the
p53 protein, express higher mucin levels and that the same is found in nasal brushings from humans. Single-
cell RNA sequencing showed that differentiated HAECArg show increased numbers of mucous cells while
HAECPro cultures show squamous cells. Therefore, genetic variants may cause susceptibility depending on the
cell type and the type of injury that initiates the chronic inflammatory condition. To begin investigating this
possibility, we generated whole genome genotyping and bulk RNA sequence data from HAECs of 185 individuals
cultured as basal cells. We identified 1,014 genes that harbored at least one expression quantitative trait locus
(eQTL) and 16 distinct loci containing known COPD-associated genetic variants including a region near MUTYH.
Based on these findings, we propose to test the hypotheses that multiple genetic loci associated with COPD
harbor eQTLs or protein QTLs that are active in airway epithelia exposed to cigarette smoke (CS). Colocalization
analysis of these QTLs with COPD genome-wide association study (GWAS) results will identify airway-specific
genes that initiate COPD development. Aim 1 will identify CS-responsive genes and pathways and link eQTLs
and protein QTLs to COPD-associated genetic variants, with MUTYH being the first identified gene to investigate.
Aim 2 will determine the role of the Tp53 variants in airway epithelial differentiation. Isogenic HAECArg and
HAECPro cultures will be compared for cell types by single cell RNA sequencing and investigate whether the
p53Arg or p53Pro variants facilitate a mucous or squamous differentiation process depending on culture conditions.
Mechanisms underlying the p53Arg-mediated expression of mucin genes will be elucidated. These studies will
help define pathways that characterize a specific COPD subtype and provide biomarkers for early diagnosis,
patient stratification. The data from HAEC185 will also provide a resource for future studies on any chronic
disease that originates from susceptible airway epithelial cells.

Public health relevance
Project Narrative The roles of the many of the susceptibility genes that have been associated with chronic diseases are not understood. The present study will identify genetic variants that modulate cigarette smoke-induced gene expression in primary airway epithelial cells from 185 individuals. The role of the genes that colocalize with genetic variants associated with COPD susceptibility will be further investigated as gene candidates responsible for initiating COPD development. Therefore, these studies will help identify novel biological processes that drive the development of COPD, and may be useful biomarkers for COPD subtypes.